Arkansas Center for Food Allergy Research (ArCOFAR)

PROJECT SUMMARY/ABSTRACT
Alpha-gal syndrome (AGS) is an IgE-mediated allergy syndrome with the key allergenic epitope denoted as the
oligosaccharide galactose-alpha-1, 3-galactose (alpha-gal) found in non-primate mammalian meat and mammal-
derived products. Patients with AGS are known to be potentially at risk for a wide variety of clinical presentations,
including delayed onset allergic reactions with exposure to alpha-gal in foods (including mammalian meat,
gelatin, dairy), medication ingredients, and medical devices.
Reactions to consumption of mammalian meat products in AGS patients manifest as IgE-mediated allergic
reactions typically with a delayed onset by 2-6 hours from exposure. Reported reactions are associated with
highly variable symptom severity including reports of anaphylaxis in some while others report cutaneous or GI
symptoms only. There is also a high prevalence of sensitization to alpha-gal without symptoms that has been
observed in populations with exposure to the relevant ticks. In IgE-mediated food allergy, the reference standard
for diagnosis is prospective oral food challenges; however, patients with positive IgE against alpha-gal have only
rarely undergone oral food challenges. The field is lacking in tests and biomarkers of disease, including
appropriate alpha-gal-free control products and standardized methods for oral food challenge, that define AGS
with diagnostic accuracy and predict disease activity. Recent FDA-approval of an alpha-gal knock-out (KO) pig
as a food source animal (Revivicor) and the commercial availability of pork products derived from these alpha-
gal KO pigs (GalSafe™) presents a unique opportunity to understand mechanistically whether the presence of
alpha-gal allergen in porcine mammalian tissues is both necessary and sufficient to trigger reactions in
participants with positive alpha-gal-specific IgE whose clinical history is consistent with allergy. It also presents
an opportunity to identify whether this product could serve as a control for future clinical trials of therapeutic
strategies in AGS. Oral food challenges with pork from alpha-gal KO and wild-type (WT) pigs also present an
opportunity to identify mechanistic biomarkers that might characterize a reaction to alpha-gal containing meat.
The Beginning to Assess an Appropriate Control for Oral Food Challenges in Alpha-Gal Syndrome
(BeACON4AG) Trial, also known as CoFAR-13, is a 4-center trial conducted within the Consortium for Food
Allergy Research (CoFAR) network and lead by Vanderbilt University Medical Center (PI, L. Bacharier) with
inclusion of 3 other centers located within regions of high prevalence of AGS, including the University of Arkansas
for Medical Sciences and Arkansas Children’s Hospital (site PI, S. Jones), the University of North Carolina
Chapel Hill (site PI, S. Commins) and the University of Virginia (site PI: J. Wilson). The study is designed to
assess the efficacy and safety of alpha-gal KO pork product as a control for double-blind food challenges (DBFC)
using a Phase II, randomized, multisite, two-period, two-sequence, double-blind, controlled cross-over trial in
participants ages 12 to 50 years old with suspected AGS. The study’s primary objective is to determine whether
the proportion of positive challenges among participants with suspected AGS is lower with alpha-gal KO pork
product as compared to WT pork during DBFC. Secondary objectives include focused evaluations among sub-
phenotypes of AGS, safety, and identification of biomarkers.
This Administrative Supplement is requested for the Arkansas Center for Food Allergy Research (U01AI181962)
as a participating site for CoFAR network trials. This request is specific to the CoFAR-13 network trial and
encompasses several purposes: 1) secure acquisition of alpha-gal containing WT and alpha-gal KO (GalSafeTM)
pork sources for testing via blinded oral food challenges, 2) supply materials to all study sites for safe preparation
of pork products and conduct of blinded oral food challenges in adolescents and adults with AGS enrolled in the
CoFAR-13 (BeACON4AG) Trial, and 3) provide support for all trial activities at ArCOFAR. Funding for the
CoFAR-13 Trial does not include the purchase of WT or KO pork required for blinded oral food challenges due
to a preliminary commitment for a cost-free supply of pork test products (WT and KO) by Revivicor (Blacksburg,
VA), the company that developed the GalSafeTM pig. The preliminary commitment was subsequently withdrawn
thus placing the trial in jeopardy of discontinuation due to a critical loss of in-kind support for study products.
This administrative supplement provides funding for durable acquisition of both alpha-gal WT and KO
(GalSafeTM) pork products for oral food challenges while also providing resources that will enhance the safe
conduct of the study without modifying the original scope of work that was awarded. These assets designated
for the CoFAR-13 (BeACON4AG) Trial are critical to enhance the infrastructure at each of the trial’s sites and
will exert a sustained and powerful influence on the trial’s impact within the field of AGS by advancing efforts to
establish clinical phenotypes and biomarkers of allergic reactions in AGS.

Public health relevance
PROJECT NARRATIVE This administrative supplement to the Arkansas Center for Food Allergy Research (ArCOFAR) U01 Award and specific to the new CoFAR-13 (BeACON4AG) Trial will provide the necessary support to preserve the trial’s impact while enhancing its safety platform. This supplement will provide financial resources to secure acquisition of safe food sources of alpha-gal wild-type and alpha-gal knock-out (GalSafeTM) pork for oral food challenges, while also providing resources to study sites that ensure safe conduct of oral food challenges by expanding equipment and supplies dedicated solely to CoFAR-13. These measures will increase the likelihood for the CoFAR-13 (BeACON4AG) Trial to exert a sustained and powerful influence by establishing clinical phenotypes and biomarkers of allergic reactions in alpha-gal syndrome.